Collagen-based tissue guidance biofabric for treatment of stress urinary incontinence in women

ABSTRACT
The prevalence of stress urinary incontinence (SUI) in women is 22% in ages 45-64 years, and up to 41% in
women over 80 years old. Synthetic polypropylene mesh slings are the current standard of care treatment, and
the market for these devices is over $400M/year. However, complications rates, including chronic pain, extrusion,
and erosion, range from 5-15%. There have been numerous class-action lawsuits against manufacturers, a
pause on SUI sling sales in the UK and New Zealand, and many patients are hesitant or unwilling to receive
these implants. Therefore, there is a strong clinical need to develop new implants to treat this debilitating and
life-altering condition in women.
CollaMedix’s patented electrochemical compaction fabrication process transforms solutions of medical-grade
bovine Type I collagen into continuous-length threads on spools that are among the densest and strongest forms
of reconstituted collagen. Collagen molecules are strictly aligned in parallel to the long axis of threads, mimicking
the native topography of ligament-like tissues. When implanted in vivo, host collagen deposited throughout
scaffolds made from these threads is also aligned, indicating that the threads act as a template, resulting in an
ordered tissue structure, not a randomly oriented scar. The collagen threads are resorbed and remodeled over
time as a strong, ligamentous tissue grows through the scaffold.
Based on this technology, CollaMedix has developed a tape-shaped, pure-collagen product for SUI treatment,
CollaSling™, composed of braided pure-collagen threads. CollaSling is implanted in the same manner as
standard SUI slings and imparts less inflammation than polypropylene over time, as shown in long-term sheep
studies. We have completed the product design and high-risk verification and validation (V&V) studies required
for FDA submission, including the full biocompatibility test suite, large animal implant study, and sterilization
method development for the CollaSling.
The aims of this study are to complete the validation work and protocol development needed to submit an
Investigational Device Exemption (IDE) to the FDA for the CollaSling and, once the IDE is approved, to initiate
and complete a 20-participant Phase I safety pilot clinical study. The pilot study will be conducted at three hospital
centers: Duke University Hospital, Cleveland Clinic, and MetroHealth. Women with SUI who volunteer for the
study will be implanted with CollaSlings using standard surgical techniques and followed carefully. An interim
safety analysis based on adverse event rates will be conducted at 3-months post-surgery, and all participants
will be followed for a minimum of one year to assess CollaSling safety and efficacy by comparing objective
measures of continence and patient-reported outcomes to previous studies on SUI slings.
Successful completion of this pilot, first-in-human trial of the CollaSling will allow the project to move forward to
a Phase II pivotal randomized controlled trial to assess its efficacy compared to the current standard of care.

Public health relevance
PROJECT NARRATIVE CollaMedix has developed a pure-collagen sling, CollaSling, for treating stress urinary incontinence in women as an alternative to current polypropylene mesh slings. The CollaSling will be resorbed in the body over time. In this project, we will complete the development of the CollaSling and conduct a 20-participant Phase I pilot clinical trial at three medical centers.